Prevention, Preparedness, and Response (P2R) Consortium

The Prevention, Preparedness, and Response (P2R) Consortium is comprised of dedicated experts in health and safety disciplines and an external advisory board of devoted and experienced professionals, the contributions of whom are critical to the nation’s health and well-being. Guided by a shared vision – to reduce the national burden of work-related harm and improve disaster preparedness and response capacity – the P2R Consortium serves as a training and educational resource for workers, responders, and community members across the country with a targeted focus on the population of U.S. Department of Health and Human Services Public Health Regions 6 and 8. The objective of our Hazardous Waste Worker Training Program (HWWTP) is to reduce work-related hazards and the objective of our HazMat Disaster Preparedness Training Program (HDPTP) is to improve disaster preparedness and response. Building on past successes and using responsive and engaging curricula, with teaching methods grounded in best practices for adult learning, the P2R Consortium anticipates delivering approximately 300 courses reaching about 25,000 learners for a goal of approximately 285,000 contact hours of training each year. In addition, the P2R Consortium places special emphasis on building the capacity of institutions and the community to respond to public health threats prior to the arrival of first responders. Thus, the public health impact of the P2R Consortium is the development and maintenance of a knowledgeable workforce, empowered with the skills and confidence to recognize, mitigate, and manage hazards and the ability to effectively disseminate this knowledge for the health and well-being of their families, colleagues, and neighbors.

Public health relevance
P2R CONSORTIUM NARRATIVE The public health relevance of the Prevention, Preparedness, and Response (P2R) Consortium is its ability to deliver practical, timely, and meaningful health and safety training to workers and communities that is practical, evidence-based, scientifically sound, and applies experience. By placing emphasis on teaching workers to recognize and mitigate hazards in the workplace and the environment, the P2R Consortium enhances the ability of workers to protect themselves and their families while also building community capacity to respond to environmental and work-related threats. In so doing, the P2R Consortium empowers workers and communities – especially vulnerable and underserved populations – to go beyond the passive receipt of information to proactively identify, prevent, and manage occupational and environmental health hazards, including emerging ones.